USE OF ANTISENSE RNA OR DNA TO INHIBIT GENE EXPRESSION

These studies are designed to analyze the effects of oncogene expression on cell growth and differentiation. We have previously shown that inducible antisense c-fos constructs can inhibit fibroblast growth, and that single stranded antisense oligomers can induce differentiation of HL-60 cells. Antisense c-myc constructs only mildly inhibit fibroblast growth, possibly because of an inability to obtain a suitable ratio of antisense:sense RNA. A more useful model system is the 32-D cell line, in which removal of interleukin-3 from the media induces a fall in c-myc and growth arrest; conversely, addition back of Il-3 induces a rise in c-myc with a subsequent re-entry into the cell cycle. Induction of antisense c-myc RNA during Il-3 induced quiescence should allow more detailed study of the role of c-myc in the cell cycle.